Cognitive Training vs. Treatment as Usual to Improve Functioning and Reduce Transition Rates in Tunisian CHR Youth: A Feasibility Study

Brief Description / Abstract:
This study will use standardized and well-established approaches that have been culturally adapted for early
detection, identification, assessment, and treatment of Clinical High Risk (CHR) youth in Tunisia, a low- and
middle-income country (LMIC) in North Africa. Being at CHR means that these are young people are at greater
risk than the general population for developing psychosis, a serious mental illness (SMI). This study proposes
to use an active, educational, community outreach approach to reduce both stigma and increase community
awareness about the availability and importance of mental health services aimed at early intervention. This
approach will aid in the identification of individuals at CHR who can receive study related treatment services.
Assessment of the CHR state will be performed by a clinical team trained to high levels of accuracy on
assessment tools that were used successfully in high income countries and have been culturally adapted and
found to be feasible for use in LMIC such as Tunisia. Once identified, these young Tunisian individuals will be
provided with a non-stigmatizing treatment that is an evidence-based practice (EBP) used in high income
countries in the delivery of mental health care. The intervention will consist of computer-based cognitive
training which is youth friendly and has been adapted culturally for use with Tunisian youth. This form of
cognitive training has been shown to improve cognitive functioning and reduce key symptoms related to
impaired functioning. The treatment will be provided in the type of rehabilitation setting which has been shown
to increase the likelihood of success. Motivational factors that increase the likelihood of participation will be
identified and strengthened. Engaging and improving cognitive performance and daily functioning is the
proposed mechanism of action for reducing the rate of conversion to more severe mental illness in these at risk
youth. The goal is to reduce the risk of progression to more serious mental illness by improving school, work,
and social functioning. These improvements in functioning are aimed at reducing the high level of distress that
is invariably experienced by individuals who suffer from difficulties in functioning. In this way, reducing stress
and improving cognitive functioning is hypothesized to improve daily functioning and decrease the downward
trajectory toward serious mental illness. Reliable and valid measurements that will be repeated over time will
be used to evaluate the impact and success of this innovative use of treatment. This study involves
strengthening an ongoing collaboration between the Principal Investigator who is a UCLA Research
Psychologist and member of the UCLA Department of Psychiatry faculty and professors from the University of
Tunis, El Manar who are published researchers and experienced clinicians. The development of this model
CHR program in Tunisia that is being proposed will be manualized and disseminated to other Middle East
North African (MENA) countries to encourage the use of similar assessment and treatment programs for CHR
youth.

Public health relevance
PROJECT NARRATIVE This R21 application in response to PAR-21-319 was inspired by a global mental health intuitive aimed at the further development of standardized and well-established and culturally adapted approaches for stigma reduction, early detection, identification, assessment, and treatment of Clinical High Risk (CHR) youth in Tunisia, a low- and middle-income country (LMIC) in North Africa. Once identified, these young Tunisian individuals will be provided with a non-stigmatizing and culturally adapted treatment that is an evidence-based practice (EBP) used in high income countries in the delivery of preventative mental health care. The development of this model CHR program in Tunisia that is being proposed will be manualized and is planned for dissemination to other Middle East North African (MENA) region countries to encourage the use of similar community outreach, assessment, and treatment programs for CHR youth in need of care.